PHASE I SAFETY &PHARMACOKINETIC CLINICAL TRIALS

The Contractor shall develop a multiple-dose safety and pharmacokinetic phase 1 clinical protocol for phenethyl isothiocyanate to evaluate the parameters of safety and toxicity and of steady-state pharmacokinetics. In addition, investigations of pharmacological and/or cancer surrogate endpoint biomarker modulation (e.g. urinary NNK metabolites and/or adducts) are encouraged. Protocol activation will occur following IRB and FDA approval and the receipt of all chemopreventive drug(s) from the NCI by the Contractor. The Contractor shall submit the protocol to NCI DCPC Protocol safety and Review Committee for review and comment, address all issues raised in the NCI review, and submit a finalized protocol for IRB approval. The Contractor shall prepare all materials necessary for FDA approval. The NCI will submit the protocol to the FDA and will hold the IND. The protocol shall include, as a minimum, a background discussion of phenethyl isothiocyanate (see the work of S.S. Hecht, G.D. Stoner, and/or F-L. Chung; see also Cancer Res. 53: 721-724, 1993).